Novel Combinations of Natural Product Compounds for Treatment of Alzheimer Disease and Related Dementias

PROJECT SUMMARY/ABSTRACT
In response to National Institute on Aging's (NIA) strategic plan and PAS-19-317, we propose novel therapeuticsto
treat Alzheimer disease and related dementias (ADRDs). We have developed novel combinations of three natural
product compounds, which modulate complementary pathways in multiple types of CNS cells (i.e., neurons,
microglia) associated with AD pathology. These compounds were originally discovered through our previous
computational systems biology research on AD target discovery and drug repurposing funded by NIA AMP-AD
consortium where we identified over 6000 potential targets and prioritized more than 3000 candidate compounds,
including natural compounds, FDA-approved drugs, and small-molecules. These compounds were identified via
analysis of multi-omics data from large-scale post-mortem brain tissues of AD patients using our computational
systems biology approach. In this project, we propose to further confirm the safety in wild-type (i.e., C57BL6/J
mice) and therapeutic efficacy using an established murine model of AD (i.e., 3xTg mice) for our novel combinations
of natural product compounds. Additionally, we will validate the correlation of our novel sex- and APOE genotype-
specific serum-based metabolic biomarkers and additional protein biomarkers with the therapeutic effects of our
treatment in this AD mice model.
We hypothesize that these natural product combinations will prove to be safe and effective therapeutics
for treatment of ADRD. To address this hypothesis, we proposed the following three aims:
Aim 1: To evaluate systemic and central toxicity of NAD+/PEITC and NADH/PEITC. In this aim, we will first
validate the compound structure and formulation stability with LC-MS and NMR. Next, we will use male and female
C57BL6/J aged 6 months and 15 months to test brain, liver, kidney, and heart toxicity of our combinations during
the acute (3 days), subacute (7 days), and chronic (28 days) periods post-dose.
Aim 2: To evaluate therapeutic effects of these drug combinations on AD Biomarkers and Functional Cognitive
Performance in 3xTg mice. Here, we will measure effects of our therapeutic combinations on brain levels of
amyloid beta proteins (i.e., Ab(1-38), Ab(1-40), Ab(1-42)) and hyperphosphorylated tau. We will also test effects
of our combinations of natural products on neurocognitive performance using the novel object recognition test
and the Morris water maze. All studies in Aim 2 will be conducted in male and female 3xTg mice aged 6 months
and 15 months.
Aim 3: To evaluate additional blood-based therapeutic biomarkers of these drug combinations. Using blood
samples collected from 15-month-old male and female 3xTg mice (Aim 2), we will validate novel blood-based
metabolic and proteomics biomarkers for evaluation of therapeutic responses of our combinations via
metabolomics and proteomics data analysis.
Our preliminary results on both in-vitro and in-vivo model have demonstrated great promise on significant
neuroprotection, stimulation of microglial phagocytosis and improving working memory of 3xTG mice. Upon the
success of this project, we will be ready to further confirm the safety and therapeutic effectsof these combinations
of compounds for MCI and/or very early-stage of AD in a clinical study.

Public health relevance
PROJECT NARRATIVE Currently, there are few effective therapeutics against Alzheimer disease and related dementias (ADRDs), which affect more than 55 million people worldwide. In this study, we propose to further investigate therapeutic effects and safety of novel combinations of three natural compounds that modulate complementary pathways in multiple CNS cell types associated with AD pathology, which have shown promising results in an animal model of AD. The success of this project will enable clinical studies in human subjects that will facilitate development of our novel natural product combinations as a new treatment for ADRD.